LUPRON THERAPY VS ORAL CONTRACEPTIVE AGENTS IN PRESERVATION OF GONADAL FUNCTION

This investigator will determine if Lo-Ovral or Depot-lupron is better at controlling menstrual blood flow during bone marrow transplantation (BMT).